Hybrid Electrical-Mechanical Pump for Vacuum Suspension of Prosthetic Sockets

Prosthetic sockets are secured to the residual limb by a variety of suspension techniques, including
mechanical (straps, pin locking liners) and suction (sealing sleeves, one-way valves, vacuum pumps) systems.
Evidence strongly suggests the benefit of vacuum-assisted suspension (VAS) over other suspension
techniques, including: reducing residual limb volume fluctuations that compromise socket fit, improving gait
symmetry, reducing relative motion between the residual limb and socket, facilitating healing of residual limb
wounds, and application to prosthesis users with short residual limbs. Commercial pump designs are either
mechanical or electrical, each having unique advantages and disadvantages. The Hybrid Integrated Pump
Project Initiative (HIPPI) began in 2010 as part of a Department of Defense funded project and resulted in the
design of pump technology that incorporates electrical and mechanical systems to achieve VAS irrespective of
the state of the user while maximizing battery life and minimizing noise. The HIPPI technology underwent
preliminary evaluation demonstrating feasibility but highlighting the need for additional enhancements. The
purpose of this project is to further design and evaluate the HIPPI system and enhance commercial-viability to
attract industry partners with whom to generate a market-ready device through future collaborative efforts. This
device would have considerable value for the Veterans Health Administration by offering technology that would
apply to active patients who desire rapid generation of VAS with minimal battery recharging, and older patients
who rely on sustained VAS without the need to continuously load their prosthesis.
While our design has attracted interest from multiple prosthetics manufacturers, design improvements must be
made to enhance commercial-viability and ensure efficacy of use in persons with amputation. These needs will
be addressed through the development activities of this work including stage-gate design processes, bench
and human subject testing, and input from stakeholders. We plan to refine the hybrid electrical-mechanical
vacuum pump design by: 1) optimizing the mechanical pump system to ensure generation of a maximum level
of vacuum comparable to existing vacuum pumps, and 2) seamlessly integrating a microprocessor-controlled
electrical pump system to monitor vacuum level and reengage the system when pressure falls below a set
minimum. During the design process, industrial design and user-centered market research will be conducted
through stakeholder focus groups and consultation with an industrial designer and our industry partner to
enhance commercial viability. Each iterative prototype of the HIPPI system will undergo bench and human
subject testing. The electrical system will be bench tested to quantify the time and rate by which the system
achieves the minimum-required vacuum level in a sealed volume, and verify that the microprocessor
recognizes when the level falls below a predefined value and activates to reestablish that level. The
mechanical system will be bench tested to quantify the number of cycles to achieve sufficient vacuum level and
verify that the device satisfies structural ISO 10328 standards (static strength and durability). A prototype will
also be assessed on individuals with below-knee and above-knee limb loss in the laboratory to verify that the
pump can achieve and sustain sufficient vacuum level between the prosthetic liner and socket during walking
but does not considerably alter socket reaction moments. The deliverable from this project will be a refined and
working HIPPI prototype that will be applicable to Veteran users of VAS irrespective of their age, gender, or
activity level. The results of this work will position us well to transfer this technology to a commercial partner
and engage with them in competitive research proposals to continue commercialization efforts and evaluate
clinical efficacy in large-scale VA clinical studies.

Public health relevance
Prostheses can be suspended from the amputated limb using a variety of techniques, such as straps and suction. Suspending the prosthesis by creating a vacuum between the prosthetic socket and limb using a pump has benefits over other techniques including improved limb health and mobility. While most pumps are electrical or mechanical, this project will develop and test a new pump that combines both systems to eliminate the limitations of each independent system. We will design a new mechanical pump and combine it with a computer-controlled electrical pump. We will discuss this pump with clinicians and prosthesis users to understand their opinion on the technology. The pump design will be tested to confirm that it works properly and is safe to use, and then will be used by prosthesis users in the laboratory to verify its functionality. This pump will be appropriate for Veterans with leg amputations of different ages and activity levels by creating a reliably secure connection to the prosthesis while reducing the need to charge the battery.